Feedback amplification between Retrotransposons/endogenous retroviruses and TDP-43 in Alzheimers related dementias

PROJECT ABSTRACT
This proposal investigates a novel idea to explain how TDP-43 protein pathology is
amplified and spread between glia and neurons after initiation of disease. TDP-43
aggregation pathology is a core feature of a suite of neurodegenerative disorders
including frontotemporal dementia, Alzheimer’s and amyotrophic lateral sclerosis. We
propose and will test the hypothesis that retrotransposons and endogenous retroviruses
are both activated by TDP-43 pathology and can be upstream initiators of such
pathology. We also will test the idea that these mobile elements contribute a mechanism
of inter-cellular spread that could underlie progression of disease. We will use both
Drosophila models and mammalian cell culture to test the core features of this proposed
model.

Public health relevance
PROJECT NARRATIVE This proposal investigates the role of retrotransposons and endogenous retroviruses in Alzheimer’s and related dementias, using a Drosophila model as well as mammalian cell culture. The primary hypothesis that will be investigated is that retrotransposons and endogenous retroviruses, which are virus like elements that reside in the genome, are both upstream initiators and downstream mediators of the protein aggregation pathology that is seen in subjects with these disorders. The proposal makes use of well established Drosophila models of neurodegeneration that are relevant to Alzheimer’s Related Dementias. By use of these models and of cell culture, this proposal also will test the idea that retrotransposons and endogenous retroviruses contribute to the spread of disease between neurons and glial cells in the brain.